Task A23: Neisseria Gonorrhoeae MIC Determination

This contract provides in vitro testing of potential anti-bacterial agents, efficacy to combat the effects of toxins produced by bacteria, maintenance of bacterial stocks, and the development of related assays.